POSTPRANDIAL HYPOTENSION IN ELDERLY SUBJECTS DURING UPRIGHT TILT

To determine if Postprandial Hypotension is augmented by the assumption of upright posture in an elderly cohort. We hypothesize that there will be a subset of elderly subjects who will demonstrate a drop in BP after a standard meal which will be exacerbated by upright tilt. We hypothesize that patients with postprandial hypotension will have lower baroreflex sensitivity & impairment in the activation of the sympathetic nervous system as measured by power spectral analysis of RR variability.